Compass: A Novel Transition Program to Reduce Disability After a Stroke

PROJECT SUMMARY ABSTRACT
Stroke is a leading cause of death and disability, with dismal 1-year outcomes for survivors. Many are
rehospitalized, fall, are admitted to skilled nursing facilities (SNFs), or die. Stroke is fundamentally a chronic
condition that is currently managed as an acute event. Acute inpatient rehabilitation (IR), focused on resolving
impairments, does not typically address the environmental barriers stroke survivors face when they return
home (e.g., stairs without railings). As a result, they leave IR without the skills to successfully reintegrate into
the community. There is a critical gap in post-acute care as chronic needs of survivors are not being met
during their transition from a medical to a community model of care. To address this gap, we developed a
novel rehabilitation transition program, Community Participation Transition after Stroke (COMPASS), a
behavioral intervention delivered in the home during the transition from IR that resolves barriers to
independence using home modifications (e.g., grab bars by the toilet) and self-management (learning to
resolve barriers independently). Feasibility and phase IIb trial results showed that COMPASS can reduce
environmental barriers in the home and may impact health outcomes such as SNF admission and death. We
now propose a hybrid type 1 randomized effectiveness-implementation trial to establish COMPASS as the
missing link between IR and home. Our central hypothesis is that COMPASS will be superior to usual care for
key outcomes and implementable in practice. The specific aims are: (1) conduct a multicenter randomized
controlled trial to evaluate the impact of COMPASS on SNF admission, death, rehospitalization, and falls
compared to enhanced usual care; (2) evaluate the quality, cost, and efficiency of COMPASS during transition
from IR to home relative to enhanced usual care; and (3) conduct a mixed-methods study informed by the
Practical Robust Implementation and Sustainability Model (PRISM) and the Reach, Effectiveness, Adoption,
Implementation, and Maintenance (RE-AIM) framework to evaluate the sustainability and implementation
potential of COMPASS. Hypotheses are: (1) COMPASS participants will have significantly lower incidence of
12-month SNF admissions and mortality, lower incidence of 30-day rehospitalization, and lower fall rates
compared to enhanced usual care; (2) the incremental cost-effectiveness ratio will be cost-effective by World
Health Organization standards, and return on investment will be positive; and (3) COMPASS will have high
reach, adoption, implementation (fidelity), and maintenance (12-month adherence) and a high potential for
implementation and sustainability. COMPASS is innovative because it augments current practice by resolving
barriers in the environment as stroke survivors transition home. This proposal is significant as it fills critical
gaps in rehabilitation evidence by investigating the therapeutic efficacy, cost-effectiveness, and implementation
potential of a novel behavioral intervention during the transition from IR. COMPASS could effectively bridge the
gap between acute and community care, reducing stroke survivors' morbidity and mortality.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Stroke is a leading cause of long-term disability and death in the U.S. When stroke survivors return home from inpatient rehabilitation, they have difficulty performing daily activities and face new environmental barriers because of new cognitive and physical impairments caused by their stroke. The proposed study evaluates the efficacy, cost-effectiveness, and implementation potential of a program delivered during the transition home from inpatient rehabilitation that is designed to reduce environmental barriers and improve daily activity performance, thereby reducing poor health outcomes such as admission to the hospital and skilled nursing facilities, falls, and death.